Advancing Diversity in Addiction Research Training

Abstract
This R25 application seeks renewal of the national Diversity in Addiction Research Training (DART) program
(DA020537-16; formerly the Drug Abuse Research Training program), designed to address the persistent
scarcity of physicians and diverse clinical researchers engaged in addiction research. Greater diversity cultivates
robust learning environments, promotes a broad array of ideas and perspectives thereby enhancing innovation,
and promotes culturally competent care to help eliminate racial/ethnic health disparities in addiction. The DART
program was initiated in 2006 at the Medical University of South Carolina (MUSC) with a primary focus on
psychiatry residents and has since expanded to include a vibrant summer research program, which enrolls
trainees from national and international institutions at the undergraduate, graduate, and medical student
educational levels. DART provides an intensive core research training curriculum including a weekly seminar
series, mentored hands-on research experience, an individualized training plan, and formal near-peer mentoring.
To date, 220 trainees have enrolled in DART and retention is excellent (only one trainee has dropped out).
Program evaluation data demonstrate that the majority of trainees remain engaged in research post-DART, and
trainees have been highly productive, generating 575 conference presentations and 353 manuscripts. During
the next five years, we will significantly expand and innovate the DART program and enhance the diversity of
trainees and faculty through new partnerships with external residency programs. We have established new
partnerships with Howard University and the University of Virginia, and plan to expand to additional residency
programs during the renewal period. In addition, we have assembled an outstanding Advisory Board comprised
of 16 diverse (67% underrepresented racial/ethnic minority [URM] faculty and 72% women faculty) and highly
accomplished researchers, educators, and leaders in the field from 14 different institutions who will bring
exceptional talent and diverse experiences, viewpoints, and areas of expertise to the DART program by providing
input, seminars, mentoring, and one-on-one career advice. We have augmented the curriculum in the areas of
(a) opioid use disorders, (b) remote/virtual clinical trials, and (c) health disparities in addiction, supported by
collaboration with the NIDA Office of Diversity and Health Disparities. During the renewal period, we aim to enroll
122 trainees with at least 50% or more URM trainees. Dr. Colleen Halliday, a faculty member at MUSC with
expertise in racial/ethnic disparities in substance use and mental health outcomes, joined the DART Leadership
Team in 2020 and will help guide targeted recruitment efforts to further enhance trainee diversity. This application
aligns with the NIH UNITE Initiative to support diversity, equity, and inclusion in the biomedical workforce and is
directly responsive to the new NIDA Racial Equity Initiative to increase racial/ethnic diversity within the addiction
research community and address critical research gaps on health disparities in addiction.

Public health relevance
Project Narrative There is a persistent scarcity of physicians and diverse clinical researchers engaged in the addiction research workforce, as reflected in the low numbers of NIDA research project awardees with an MD (15% in 2020) and even fewer awardees from underrepresented racial/ethnic minority (URM) populations (less than 4%). Research training programs, such as the Diversity in Addiction Research Training (DART) program (DA020537-16; formerly the Drug Abuse Research Training program), for which this application seeks renewal, will increase the number of URM investigators by involving more URM trainees in the research training pipeline earlier in their education. Greater diversity cultivates robust learning environments, fosters creativity and innovation, and promotes culturally competent care, all of which will help reduce racial/ethnic health disparities in addiction and associated mental health conditions.